Rio Grande Valley Cancer Health Disparity Research Center

The Rio Grande Valley (RGV), located in South Texas along the US-Mexico border, is home to Hispanic/Latino
American (HA/LA) populations who disproportionately suffer from several cancers despite improvements in the
last several years in overall health care (diagnosis and treatment). The proposed Rio Grande Valley Cancer
Health Disparity Research Center (RGV-CHDRC), located at the university of Texas Rio Grande Valley
(UTRGV), will develop a comprehensive, biomedical research infrastructure building capacity to reduce cancer
chronic disease disparities in the RGV region using multi-domain and multifactorial (basic, clinical, behavioral,
social, biological) cutting-edge research, engaging relevant community partners/stake holders, and developing
local health disparity research workforce. This center will establish collaborations with local and national
educational, research, and medical institutions as well as nationally renowned research-intensive institutions,
such as University of Texas MD Anderson Cancer Center, University of Texas Southwestern, and Baylor College
of Medicine. We propose three research projects: 1) a basic biomedical research project on etiology of liver
cancer, 2) a social/behavioral research project on prolonged psychosocial stress cancer and 3) a clinical and
health service research project on cervical cancer and HPV screening, along with four cores - Administrative
Core, Investigator Development Core, Community Engagement Core, and Research Capacity Core. The
proposed research projects will delineate molecular and socio-behavioral determinants of health, influences of
cancer and its associated chronic diseases health disparity, clinical manifestation of early cancer diagnosis, and
if socio-behavioral interventions that can reduce burden of these chronic diseases and improve quality of life of
the cancer patients. These projects will conduct basic and clinical translational research to improve early
diagnosis of liver and cervical cancers and develop strategies to enhance therapeutic outcomes of
chemotherapies by applying culturally tailored interventions. This U54 application will foster and promote
collaboration between research projects and core facilities, engage community partners, and facilitate translation
of science into practice. The main objectives of our RCMI application are to: 1) Enhance biomedical research
infrastructure and capacity building at UTRGV and in the RGV; 2) Conduct impactful research on variable factors
associated with cancer disparities; 3) Develop relationships and establish collaborations among local and top
tier research institutions, 4) Offer advance level training and mentoring opportunities for minority students and
faculty members across the region; 5) Disseminate scientific knowledge from the project to the local community
partners, researchers and stake holders. These activities will be crucial for developing successful intervention
strategies to eliminate cancer and chronic diseases and health disparities in RGV populations. This funding will
allow NIMHD to have its footprint in the RGV and provide NIMHD access to the unique Hispanic population data.

Public health relevance
Project Narrative: Significant cancer health disparities exist among Rio Grande Valley (RGV) Hispanic populations; however, biological, clinical, and other confounding factors contribute to these disparities are poorly understood. The proposed Rio Grande Valley Cancer Health Disparity Research Center (RGV-CHDRC) will develop a comprehensive biomedical research infrastructure and capacity building to reduce cancer and chronic diseases disparities in RGV region using multi-domain and multifactorial (basic, clinical, behavioral, social, biological) cutting-edge research, engaging relevant community partners/stake holders, and developing local health disparity research workforce. These activities will be crucial for developing successful intervention strategies to eliminate cancer and its associated chronic diseases health disparities in RGV populations, provide NIMHD access to this unique Hispanic population data and will allow NIMHD to have its footprint in the Rio Grande Valley.